Cognitive and Neurophysiological Function in Healthy Aging and Dementia

The pattern of regional cerebral blood flow was assessed in human subjects during positron emission tomography (PET) activation with a face matching task. The pattern correlated with performance accuracy in healthy young and elderly subjects. It showed higher activity in the left fusiform and lingual gyri and right frontal association regions with relatively lower activity in bilateral occipitotemporal regions. Premorbid intellectual ability was inversely correlated with regional cerebral glucose metabolism (rCMRglc), measured with PET in regions of association cortex in Alzheimer disease (AD) patients. Among AD patients, early age at onset of dementia was related to greater impairment on measures of visuospatial function. AD patients with a family history of dementia showed greater rCMRglc deficits in frontal association regions. A unique neuropsychological profile was observed for a subgroup of AD patients with early prominent visual disturbances, who had more severe visuospatial difficulties but better memory performance than typical AD patients. These patients also showed greater hypometabolism in parieto-occipital and calcarine cortices with relative sparing of paralimbic regions compared to typical AD patients. Visuospatial attention during visual search showed incremental slowing of reaction time with parametric increases in attentional distracters. Attentional slowing was greater in healthy elderly than young controls. AD patients showed less benefit than controls by decreasing cue size in the visual attention task. Despite poor figure reproduction across multiple learning trials, AD patients with mild and moderate-to-severe dementia showed some acquisition of visual material during figure reproduction that predicted recognition performance and that was unrelated to the degree of visuospatial impairment. Long-term memory and orientation declined with age among non-demented Down syndrome adults, whereas language and other functions remained preserved. Basic language skills were inversely correlated with apolipoprotein genotype in non- demented Down syndrome adults.